A Systems Approach to Discover Sensors and Regulators of the Mitochondrial Genome

Abstract
Over their ~1.5-billion-year evolution from a bacterial endosymbiont, mitochondria have retained genes
essential for energy metabolism on their own distinct genome (mtDNA) in almost all eukaryotes. Human mtDNA
encodes 13 core proteins in the respiratory chain and varies up to 10,000-fold in copy number from ~100 in blood
to ~half a million in the unfertilized egg, with each cell maintaining an intrinsic, optimal setpoint via yet unknown
mechanisms. A decline in this setpoint causes rare but severe disorders with no proven therapies and underlies
the common age-related mitochondrial dysfunction with relevance to Parkinson’s and Alzheimer’s Disease.
In my K99 phase, I propose to address two major unmet needs in clinical and basic mitochondrial biology
– to overcome the detrimental consequences of mtDNA loss and to understand homeostatic regulation of mtDNA
copy number. Genetic studies in yeast, trypanosomes, and my published work in human cells, reveal a
conserved link between membrane potential and tolerance to mtDNA loss. In aim 1, I will determine the
mechanism by which boosting membrane potential rescues the growth of mtDNA-depleted cells. My completed
multi-omic profiling of mtDNA depletion and repletion states has identified a small number of candidate effectors
of membrane potential which I will test using a drug that targets stress signaling, a metabolite that can be
supplemented exogenously, and a protein prosthetic for redox manipulation pioneered by my mentor’s lab. In
aim 2, I will take a more unbiased approach and systematically identify nuclear regulators of human mtDNA copy
number for the first time using a FACS-based genome-wide CRISPR knockout screen, which I conceptualized
and developed in my early postdoctoral work. While my K99 focuses on mtDNA sensing and regulation within
the mitochondrial matrix, my R00 (aim 3) examines the pathways and immunogenic consequences of mtDNA
leakage to the cytosol which is highly relevant to autoimmune disorders. Thus, my independent research
program aims at a synergistic culmination of postdoctoral training in mitochondrial systems biology and PhD
expertise in innate immunity.
Through my K99 goals I will master the theory and experimentation of bioenergetics and get hands-on
training in high-throughput genetics, from screen design to computational analysis. My mentor, Dr. Vamsi
Mootha, is a world leader with >20 years of experience in precisely the field of my proposed training –
mitochondrial systems biology – and has propelled over a dozen trainees into thriving academic research
careers. I have a diverse advising committee with local and national experts relevant to my proposal, including
one junior faculty member in my department and one immunologist for specific guidance at the R00 transition.
Thus, with the NIH Pathway to Independence award, I will train towards my long-term goal of launching my own
laboratory and discovering basic molecular mechanisms underlying mitochondrial and autoimmune diseases.

Public health relevance
Project Narrative Our mitochondrial genome (mtDNA) holds instructions that make mitochondria the “powerhouses of the cell”, but there is growing awareness that mtDNA can also trigger autoimmune response and collateral damage. I will examine the molecular machines that control this yin and yang of mtDNA. Through the K99/R00 award, I will train towards becoming an independent academic investigator and discover basic mechanisms relevant for treating both mitochondrial and inflammatory diseases.